Assessment of Dissolved Phase 129Xe as a Biomarker for gas-exchange and vascular function in asthma

PROJECT SUMMARY
Asthma, the most common respiratory disease in the US, affects nearly 10% of the population and costs nearly
$50 billion annually. While many asthma patients can control their asthma with inhaled medications, some patients
cannot. Although asthma is a disease characterized by airway inflammation and impaired ventilation, recent
evidence suggests that anomalies in pulmonary vasculature may also contribute to asthma presentation and
severity. This is a difficult hypothesis to address however because it requires a test that can accurately assess
pulmonary vasculature non-invasively with high spatial and temporal resolution. Furthermore, for diseases such as
asthma which are known to be spatially heterogeneous within the lung, regional vascular function is necessary to
understand the spatially heterogeneous nature of the disease – something which global measures of gas exchange
function such as DLCO lack. Treatments for asthma often target one component of the underlying pathophysiology
(airways/ventilation) while leaving anomalies in gas-exchange/perfusion unaddressed and unmanaged. Thus, the
lack of a robust, sensitive, non-invasive biomarker for pulmonary vascular function presents an unmet need in
understanding and managing individual asthma patients. Hyperpolarized 129Xe MRI is a technique in which the
nuclear magnetic moment of 129Xe is greatly enhanced in situ such that the gas itself can be imaged by MRI.
Subjects inhale a small quantity of xenon during an MR exam, and the gas is imaged as it is physiologically
distributed within the lung airspaces. The xenon can also diffuse slightly into the tissue and blood whereupon it
experiences an MR chemical shift. This allows for the xenon to be separately imaged in three distinct physiological
environments: alveolar airspaces (gas), tissue and blood plasma (membrane), and in red blood cells (RBC). The
RBC component further demonstrates oscillation due to cardiac activity – another marker of cardiopulmonary
function. Thus, within a single breath-hold 129Xe MRI can be used to image three components of lung function:
ventilation, perfusion, and gas exchange. Because hyperpolarized 129Xe MRI provides quantitative, regional
measures of both perfusion and gas-exchange we hypothesize it is a technique which can reveal the precise nature
of vascular involvement in asthma. In this work we hypothesize that in some patients with asthma, 129Xe MRI will
depict abnormalities of lung perfusion spatially separate from ventilation abnormalities and that the abnormalities
of lung ventilation, perfusion and gas exchange will respond to treatment with bronchodilator (albuterol). We will
perform 129Xe MRI in mild, moderate, and severe asthma patients and healthy controls before and after
administration of albuterol. We will quantify abnormalities in pulmonary vascular function, measure the percent of
lung with impaired ventilation and perfusion in individual subjects, and evaluate regional responses of 129Xe MRI to
bronchodilators and pulmonary vasodilators. We anticipate that there will be significant variability in the degree of
pulmonary ventilation and perfusion impairments among asthmatics of the same severity.

Public health relevance
PROJECT NARRATIVE Although asthma is often thought of as a disease of the airways, there is increasing evidence that the pulmonary vasculature may play an important role in disease presentation and control. Hyperpolarized 129Xe MRI is a technique in which quantitative maps reflecting ventilation, perfusion and gas exchange can be produced thereby providing the needed information for investigation of vascular function in lungs. We hypothesize that the vascular component of asthma can be directly quantified using hyperpolarized 129Xe providing a direct measurement of regional vascular function and potentially introducing a new target for management which may improve outcomes.